A Translational Bioinformatics Approach for Phenotyping and Genetic Risk of Severe Cutaneous Adverse Drug Reactions

PROJECT SUMMARY
Drug reaction with eosinophilia and systemic symptoms (DRESS) is a life-threatening severe cutaneous adverse
drug reaction (SCAR). Vancomycin is the first-line treatment for multidrug-resistant gram-positive bacteria and
is the most common drug associated with DRESS in the United States (US). Vancomycin DRESS is strongly
associated with HLA-A*32:01, and approximately 20% of patients carrying HLA-A*32:01 develop DRESS after
more than 2 weeks of vancomycin exposure. This underscores a vital knowledge gap that exists for all HLA-
associated SCAR: what co-morbidity, genetic, and other multi-omic risk factors that interact with and without
HLA confer susceptibility or resistance. By leveraging electronic health record (EHR) linked DNA biobanks, this
project will discover co-morbidity, genetic, multi-omic, and other risk factors for vancomycin DRESS through an
innovative translational bioinformatics approach to inform mechanisms of drug hypersensitivity and tolerance.
In this K08 proposal, I will undertake critical training for my long-term career goal of bringing precision medicine
to SCAR and other allergic/immunologic conditions by developing and applying expertise in allergy/immunology,
immunogenomics, and translational bioinformatics. The project will be completed under the guidance of my
primary mentor Dr. Elizabeth Phillips, and a Research Advisory Committee of experts in bioinformatics and
immunogenomics. By integrating targeted immunogenomic typing, including HLA, KIR, and ERAP and GWAS-
level genotyping, I will discover epistatic interactions of HLA/KIR/ERAP and multi-omic variation in vancomycin
DRESS, which has the potential to apply to other allergic and immune-mediated diseases such as cancer,
autoimmune and infectious diseases. My mentored research project has two specific aims: Aim 1: Develop EHR
phenotyping algorithms to identify DRESS cases and utilize machine learning on routine laboratory values to
develop predictive models for earlier diagnosis. Aim 2A: Confirm the association of HLA-A*32:01 and
vancomycin DRESS in a large prospective cohort; discover additional genetic variation outside of HLA through
GWAS and targeted immunogenomic typing; and, importantly, assess the generalizability of the HLA-A*32:01
association to diverse populations in other EHR biobanks. Aim 2B: Perform multi-omic analyses and causal
discovery methods to test the hypothesis that genetically regulated transcriptomic, proteomic, and metabolic
traits vary between vancomycin DRESS cases and vancomycin-tolerant controls.
Through the skills and mechanistic insights gained by this career development award, I will develop a research
niche to design and implement future studies on SCAR and other allergic/immunologic diseases that leverage
translational bioinformatics in diverse EHR biobanks, such as the NIH’s All of US cohort, eMERGE Network and
others across the US and globally. Through this career development award, I will gain the foundation to
independently lead a multi-disciplinary research team in future R01 proposals to bring precision medicine
approaches to SCAR that will translate to strategies for prevention, earlier diagnosis, and targeted therapies.

Public health relevance
PROJECT NARRATIVE Severe cutaneous adverse drug reactions are life-threatening, associated with long-term morbidity, potentially preventable, and human leukocyte antigen (HLA) restricted immune-mediated adverse drug reactions. Using a translational bioinformatics approach, we will assemble one the largest cohorts of vancomycin-induced drug reaction with eosinophilia and systemic symptoms (DRESS) as a model to identify what comorbidities, genetic, and other multi-omic risk factors interact with HLA to confer the resistance or susceptibility to DRESS. This research will enable treating clinicians to better prevent, diagnose, and treat severe cutaneous adverse drug reactions, bringing personalized care to patients.